Mechanistic underpinnings of pragmatics in ASD: Insights from FMR1-mutation conditions

Project Summary
Impaired pragmatic (i.e., social) language is a defining symptom domain of autism spectrum disorder (ASD) and
imposes significant burden on affected individuals and their families throughout the lifespan. A wealth of evidence
demonstrates that pragmatic abilities are highly heritable and are a primary feature of the broad autism
phenotype (BAP) seen in unaffected relatives of autistic individuals. Further, pragmatic language differences that
mirror those in ASD and the BAP are observed in carriers of FMR1 mutation conditions (e.g., fragile X syndrome
and the FMR1 premutation), implicating this high confidence ASD risk gene in the ASD pragmatic phenotype. In
addition to being valuable targets for intervention, pragmatic language abilities also appear to be sensitive to
genetic liability to ASD, and so can provide a window into the biological origins of ASD symptomology. Extensive
evidence from our prior work and current NIMH-funded R01 (R01MH091131) has reported overlapping profiles of
impaired pragmatic language and related molecular-genetic and neurobiological correlates in ASD and in FMR1
mutation carriers. In this project, we advance this work by investigating the mechanistic origins of these
differences, with a focus on motor-speech abilities shown to be disrupted in ASD and the BAP which are related
to pragmatic language skills, in carriers of the FMR1 premutation (PM), to illuminate gene-brain-behavior
pathways associated with this core ASD symptom domain. Preliminary data show robust differences in motor-
speech skills among PM carriers that are qualitatively similar to those observed in ASD and the BAP, and which
relate to high-order pragmatic-related abilities and neurobiological and molecular-genetic variation. Specifically,
Aim 1 characterizes the motor-speech skills that contribute to ASD-related pragmatic profiles in PM carriers
through a targeted battery of assessments indexing mechanistic contributors to pragmatic language including
speech articulation, audio-motor synchronization, rhythmic speech fluency, and auditory feedback control. Aim
2 examines associations between targeted motor-speech skills and profiles of core, high-order pragmatic abilities
in PM carriers. Finally, Aim 3 investigates both neural and molecular-genetic influences on motor-speech skills
and their relationship to broader ASD-related pragmatic profiles in PM carriers. Together, these aims will inform
the complex relationships between neurobiological and genetic markers, motor-speech mechanisms, and ASD-
associated pragmatic abilities that may be linked with FMR1-related variation. This theoretically driven, targeted,
and efficient study design will leverage rich and extensive existing data to uniquely reveal mechanistic and
biological origins of this significant ASD clinical symptom domain. Findings from this work may hold important
clinical-translational implications for the ASD and FMR1 communities, informing mechanistic intervention targets
and diagnostic markers for ASD and FMR1 mutation conditions, paving a pathway toward precision medicine
focused on underlying causes of impairment.

Public health relevance
Project Narrative This study builds on a larger parent R01 project to study how motor-speech characteristics contribute to the social communication differences that characterize autism and have been linked to a specific autism candidate gene, FMR1. The project focuses on carriers of the FMR1 premutation, to understand the different skills that contribute to social communication impairments in autism, and how they may be linked to neurobiological and molecular genetic factors. Outcomes of the study may have significant clinical-translational implications, benefiting both the autism and FMR1 communities and paving the way for more effective interventions and precision medicine approaches.